UPR Center for Incubator and Technology Transfer (UPRCITT)

UPR Center for Incubator and Technology Transfer (UPRCITT)
We propose establishing the UPR Center for Incubator and Technology Transfer (UPRCITT) at the
University of Puerto Rico (UPR) for entrepreneurial collaborative scientific research across multiple
disciplines. In our endeavors for the UPRCITT, we will fit out an entire floor (20,000 ft2) in our eight-story
UPR Molecular Sciences Research Center (MSRC), in the heart of San Juan, Puerto Rico (PR). With the
establishment of the MSRC, the UPR has sought to foster an innovative and technologically driven economy
that will generate businesses and jobs in PR (manufacturing or otherwise). Situating the UPRCITT in the
MSRC would go a long way toward making this a reality. The UPRCITT floor would provide future
collaborators with access to many of the Island’s best scientists, as well as much of the most sophisticated
instrumentation available; and our GLP-compliant animal facilities. Furthermore, scientists accepted into the
incubator space will have the opportunity of interacting within multidisciplinary research groups currently
conducting research in nanotechnology, chemistry, biosensors, vaccine development, cell biology, natural
products, structural biology, and other areas. The MSRC's ongoing efforts will provide leverage to the
UPRCITT in attracting new researchers, small businesses, and Biotech and Pharmaceutical collaborators. An
example of this being the creation of the Clinical Bioreagent Center (CBC), an NIH-NINDS-funded
collaboration between UPR and local Biotech companies in PR for the development of a prophylactic HIV
vaccine, and other new start-ups. The UPRCITT floor will include GLP/cGMP research facilities as well as
flexible laboratory spaces for transitioning basic research concepts into pilot commercial projects. These
projects could flourish for a time within the MSRC while de-risking the technology. The main goals of the
UPRCITT are: (1) to enhance PR’s economic development by founding an innovation ecosystem that will
stimulate the creation and incubation of start-up companies by providing cGMP state-of-the-art laboratories and
CORE facilities, (2) to promote collaborations among Biotech and Pharmaceutical companies and UPR
researchers, and (3) to provide workforce development by training for faculty, underrepresented
undergraduate/graduate students and postdoctoral fellows to work in teams in an innovation ecosystem which
will promote the culture of entrepreneurship in PR. The UPRCITT will promote PR's economic development in
three ways: (1) Research conducted in these facilities will be critical to PR's economic development, in terms
of both job creation on the island and spinoff projects that could be licensed and commercialized nationally.
(2) The cGMP facilities will be used to form strategic alliances with industry, provide services to industry, and
assist in capitalizing on new discoveries both within and outside of PR. (3) The facility will serve as an
entrepreneurship and innovation training facility for underrepresented students aspiring to join the US
scientific workforce. This application represents an unprecedented transformation in the UPR's research
enterprise that will propel scientific discoveries into commercialization and economic growth.